Function and Regulation of the BCL-2 Family

PROJECT SUMMARY
The impact of the mitochondrial pathway of apoptosis on cancer biology is broad because the BCL-2
(B-cell CLL/Lymphoma 2) family regulates tumor initiation and maintenance, and is directly targeted by anti-
cancer therapies. Therefore, a mechanistic understanding of BCL-2 family function will advance our knowledge
of the pathways that cause cancer, and are clinically targeted to cure cancer. The mitochondrial pathway of
apoptosis proceeds when the BCL-2 family collaborates to compromise the outer mitochondrial membrane
(OMM). This process, referred to as mitochondrial outer membrane permeabilization (MOMP), allows for pro-
apoptotic factors within mitochondria to gain access to the cytoplasm, which leads to caspase activation and
rapid dismantling and removal of the targeted cell. BAX (BCL-2 associated X protein) is the major pro-apoptotic
BCL-2 protein that engages MOMP by creating proteolipid pores in the OMM. BAX-dependent MOMP inhibits
tumorigenesis, and on the flipside, BAX-dependent apoptosis is induced by a majority of conventional and
targeted chemotherapeutics. In order for BAX to gain pro-apoptotic function, it has two general requirements:
(1) BAX needs to interact with a subset of the pro-apoptotic BCL-2 family: the “direct activator” BH3-only
proteins, e.g., BID and BIM; and (2) BAX requires stable interactions with mitochondrial lipids to structurally
rearrange leading to BAX’s insertion, oligomerization, and pore formation. While decades of research have
focused on understanding the first requirement, little has been discovered on how mitochondrial environment
mechanistically contributes to MOMP. Over the years, my laboratory showed that mitochondrial environment
directly controls BAX function, and the mitochondrial-produced 16-carbon sphingolipid metabolite 2-trans-
hexadecenal (2-t-hex) is required for BAX activation and BAX-dependent apoptosis. By utilizing novel
mitochondrial model systems coupled with state-of-the-art biochemical, cellular, and structural techniques, we
are now ready to determine the mechanistic contributions of 2-t-hex within the BAX activation process, and
more broadly, to reveal how 2-t-hex binding defines functional classifications within the BCL-2 family.
Furthermore, we generated evidence that cancer cells specifically disrupt the cooperation between BAX and 2-
t-hex leading to apoptotic resistance – and identified ‘first-in-class’ small molecules to overcome this
phenotype. Our broad objectives are to build a foundation of novel mechanistic insights into the role of 2-t-hex
on BAX-dependent apoptosis and the BCL-2 family, and to use this information to develop novel therapeutic
strategies against cancer. These objectives will be accomplished in three complementary aims: (1) Define the
molecular mechanism of 2-t-hex mediated BAX activation; (2) Elucidate the molecular mechanism by which S-
nitrosylation of BAX promotes apoptotic resistance in cancer; and (3) Identify, refine, and characterize “first-in-
class” therapeutics that transform S-nitrosylated BAXCys62 from apoptosis-resistant to apoptosis-competent thus
promoting chemotherapeutic success.

Public health relevance
PROJECT NARRATIVE Cancer occurs when cells acquire changes that convert them from a normal to malignant state. Apoptosis is a program of cellular suicide that eliminates damaged cells to prevent cancer; yet the body also turns on this program following chemotherapy and radiation treatments in order to kill cancer cells. Therefore, it is important to investigate the pathways that control apoptosis to understand how cancer occurs and should be treated.